Pathological consequences of altered tissue mechanics in fibrosis

PROJECT SUMMARY
Cells and tissues are mechanosensitive. Many
and
tissues, including the liver, are subjected to mechanical stresses
deformed over multiple time and length scales; these can both be altered in disease and drive disease.We
have used in vitro experimentation and theory to show that tissue mechanics are an emergent property,
arising from and requiring three components: the complex fibrous network of the extracellular matrix (ECM), the
cells within that network, and the forces applied to the combined system. Our work in the three years of the past
project period has specifically examined the microarchitecture and features of complex fibrous networks, the role
of cytoplasmic inclusions and cytoskeletal networks on cell mechanics, and the impact of viscoelasticity on cell
and tissue behavior. Collectively, this work has resulted in the development of a multi-axial model of a tissue.
Notably, however, while significant strides have been made in understanding tissue elasticity, viscous dissipation
and plasticity have been little studied, and the relationship between mechanics and structure – to the point that
one can be predicted from the other – remains poorly understood.
The overall goal in this competing renewal proposal is to demonstrate the in vivo applicability and predictive
value of the concepts we have defined. Specifically, we propose to determine the contribution of the individual
components of tissues to emergent tissue mechanics and the impact of these mechanics on cell behavior. Our
model tissue in this proposal, as in previous project periods, is the normal, fibrotic, and cirrhotic liver. although
our findings will be generally applicable to other organs in the body.
We hypothesize that tissue mechanics including viscous dissipation can be described and predicted by
integrating the features of the ECM fibrous network, the cells, and the applied forces. There are three specific
aims: 1) to determine the relationships between matrix structure and viscous dissipation, elasticity, and plasticity
in normal and diseased tissue; 2) to determine the impact of cell properties and cell-matrix organization on tissue
mechanics, particularly viscosity; and 3) to measure tissue solid stress and interstitial fluid pressure in normal
and diseased tissue and to define the impact of these forces on tissue mechanics, including dissipation. These
specific aims will use experimentation and theory as well as machine learning approaches to predict the
relationship between structure and mechanics, guide interventions, and generate a unified and therapeutically-
targetable model of tissue mechanics in disease.
We have previously identified many of the design principles underlying tissue mechanics. In the proposed work,
we will further define the critical components of the three elements underlying tissue mechanics, asking whether
we can predict mechanics (and their effects on cells and metabolism) from structure. This proposal thus has the
potential to answer fundamental questions in tissue mechanics, and to suggest approaches to manipulating
mechanics in clinically-relevant ways.

Public health relevance
PROJECT NARRATIVE We previously showed that the mechanical properties of tissues are an emergent property, arising only from the when the components of the tissue (cells and the extracellular matrix) are combined. The overall goal of this competing renewal proposal is to expand our understanding of complex tissue mechanics to specifically include viscosity, to define how cells, the matrix, and forces acting on tissues combine to determine tissue mechanics, and to determine the impact of these mechanics on cell behavior. The model tissue in this proposal, as in previous project periods, is the normal, fibrotic, and cirrhotic liver.